Commercialization of a Behavioral Digital Health Program for Individuals with Chronic Pain

2Morrow, Inc. CRP Grant Application – Project Summary:
Chronic pain affects roughly 1 in 5 adults. Managing chronic pain is complex, and the reality for most patients
is that living a life free of pain is unlikely. Over 50% of patients with chronic pain also experience depression or
anxiety, and medical providers often lack the time, training or resources to address these emotional challenges.
This can leave patients feeling uncared about and providers feeling frustrated. Despite national guidelines that
recommend incorporating scalable behavioral interventions when managing pain, there continues to be an
overreliance on addictive pain medications. Given the need for HEAL-aligned pain management options such
as behavioral-based treatments, 2Morrow set out to design, develop, and test a novel evidence-based digital
behavioral therapeutic for individuals living with chronic pain with FAST-TRACK SBIR HEAL grant funding (#1
R44 AT 11593) aimed at reducing the negative impact of pain on daily life with educational content, skill
development, pain awareness tools, and coaching. Our SBIR feasibility RCT study is nearing completion
(August 2024) and shows strong engagement, positive feedback, and a decrease in pain interference. Our
focus is now shifting to dissemination and commercialization. The landscape for digital therapeutics presents
unique challenges, notably in the realms of investment expectations and the absence of established payment
and commercialization models. This complexity is compounded by the fact that, typically, it takes about 17
years for evidence-based practices to gain widespread adoption in the medical community. To counter this
trend and expedite the integration of our digital therapeutic, we need to validate commercial traction. Thus we
are applying for this HEAL Commercialization Readiness Pilot (CRP) Program: Embedded Entrepreneurs for
Small Businesses in Pain Management (SB1 Clinical Trial Not Allowed) that will fund the hiring of a Chief
Commercial Officer (CCO) to accelerate the dissemination and commercialization of this product by focusing
on partner development.
Specific Aim 1: Hire a fractional (50% effort) CCO or equivalent experienced professional. Specific Aim 2:
During the first 90 days, the CCO will review, validate, and update 2Morrow’s commercialization plan. To do
this they will meet with the 2Morrow team, and at least 10 stakeholders or industry experts to 1) understand the
landscape and current business models, 2) understand current options and workflow, and 3) validate/refine
2Morrow’s go-to-market strategy. Specific Aim 3: The CCO will execute the commercialization/partnership
plan with a focus on advancing a business development pipeline that leads to key milestones such as a signed
partnership agreement or strategic investment.

Public health relevance
2Morrow, Inc. CRP Grant Application – Narrative: Chronic pain affects 50M adults in the US, and there is a need for non-addictive treatment options. With an SBIR grant, 2Morrow developed a behavioral digital therapeutic for those living with chronic pain. In the current economy, 2Morrow must show both clinical and commercial traction in order to attract funding, M&A, or larger clients; however, we need an experienced commercial executive to lead, implement, and drive commercialization for this innovative intervention.